OXYSTEROL BIOMARKERS FOR NIEMANN-PICK C DISEASE

DESCRIPTION (provided by applicant): Niemann-Pick type C1 (NPC1) disease is a rare, progressive neurodegenerative disorder characterized by accumulation of cholesterol and other lipids in the viscera and central nervous system. A barrier to the development of treatments for NPC1 disease is the lack of readily quantifiable outcome measures to evaluate efficacy of therapy in clinical trials. Through broad-based metabolomic efforts, we have discovered in NPC1 subjects cholesterol oxidation product (oxysterol) biomarkers that reflect the unique intersection of oxidative stress and unesterified cholesterol storage - the biochemical hallmark of NPC1 disease. This proposal tests the highly innovative hypothesis that oxysterol biomarkers, together with other cholesterol homeostatic markers, can serve as outcome measures to assess the effect of disease-modifying therapies (e.g., 2-hydroxypropyl-β-cyclodextrin, HP-β-CD) on cholesterol metabolism in the CNS and to monitor disease progression. 24(S)-HC, which is synthesized almost exclusively in large neurons in the CNS, and CSF cholesteryl esters (CE) offer potential quantitative, non-invasive metrics to guide dosing and to monitor drug response. Likewise, cholestane-3β, 5α, 6β-triol (triol), which we have previously shown to be elevated in the CSF of NPC1 subjects, will inform with respect to the effect of HP-β-CD on intraneuronal cholesterol storage. This hypothesis will be tested in NPC1 animal models administered intracerebroventricular (ICV) HP-β-CD (Aim 1), and in NPC1 human subjects enrolled in a natural history study and in a Phase 1 trial for ICV HP-β-CD at the NIH Clinical Center (Aim 2). The proposal will also explore the possibility that the exceptional receiver operating characteristics (ROC) of the triol assay can be harnessed to develop a newborn screen to identify NPC1 patients earlier and thus intervene in pre-symptomatic patients (Aim 3). The proposed newborn screen for NPC1 disease is innovative and would be the first for a non-enzymatic lysosomal disorder, as well as the first for an inborn error of sterol metabolism. While the goal of this project is to develop a prototype newborn screen for NPC1 disease suitable for implementation at the statewide or regional level, the tandem mass spectrometry methods developed for extraction and detection of the oxysterols could be readily extended to metabolites that accumulate in other sterol disorders (e.g., Smith-Lemli-Opitz Syndrome), thereby permitting multiplexed screening for several inherited disorders within the context of a single screen. The studies in this proposal are highly significant because we address the critical unmet therapeutic and diagnostic needs of NPC1 disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Niemann-Pick type C1 (NPC1) disease is a rare neurodegenerative disorder characterized by accumulation of cholesterol and other lipids in the brain and other organs. Children affected by the disease show symptoms in early childhood, experience progressive impairment of motor and intellectual function, and usually die in adolescence. NPC1 disease is extraordinarily difficult to diagnose, and there are no FDA-approved therapies for this disorder. A barrier to the development of therapies for NPC1 disease is the lack of outcome measures for clinical trials. The goals of this project are to test whether new biochemical markers ("biomarkers") can be used to evaluate therapies and whether these biomarkers can be used to screen newborns for NPC1 disease.